Clinical and Translational Science Collaborative of Cleveland

Clinical and translational (C/T) research is essential to bring the discoveries of biomedical science to benefit the
health and well-being of our nation. The Clinical and Translational Science Collaborative (CTSC) of Cleveland,
a collaborative among Case Western Reserve University (CWRU) and its affiliated hospital systems, the
Cleveland Clinic (CC), MetroHealth (MH), University Hospitals (UH), and the Louis Stokes Veterans
Administration Medical Center (VA), aspires to be a catalyst for high quality C/T research both locally and
nationally. The CTSC operates as a fully integrated cooperative, collaborative, and confluent research
environment that supports all aspects of clinical and translational science, enabling full access by university
faculty at all partner institutions to all CTSC-associated potential collaborators and research resources. It has
positioned itself to assume leadership in disseminating best practices and promoting multi-site clinical research.
It now seeks funding to support the development of program support required to advance the goals set forth by
the 2013 recommendations for the CTSA Program by the IOM (now NAM). The CTSC of Cleveland has created
a solid foundation on which to build from, to utilize the power of this collaborative to ensure rigorous and
innovative training of the C/T/ workforce, to accelerate the translation of discoveries to patients, to improve the
health of Cleveland, and to provide scalable models for other locations throughout the nation. To realize its
vision, the CTSC of Cleveland proposes to engage all C/T science stakeholders, the workforce, patients and
community members to collaborate locally, regionally, and nationally, to 1) advance human health, 2) develop
and cultivate the current and next generation C/T research workforce, with special focus on preparation for team
science and increasing the diversity of the workforce, 3) promote integration of our translational processes from
discovery through clinical trials, of our community throughout the research enterprise, and of special and
underserved populations into C/T research across the lifespan, 4) increase the quality and efficiency of C/T
research, particularly multi-site trials, through innovative methods and processes and strong collaboration among
CTSC Hubs, and 5) provide innovative informatics to support the training and research environment both within
the CTSC and nationally. The CTSC has designed an Administrative Core, six C/T research components:
Informatics, Community and Collaboration, Translational Endeavors, Research Methods, Hub Research
Capacity, and Network Capacity; and two formal C/T training cores: Institutional Career Development Core
(KL2), and the NRSA Training Core (TL1) to accomplish its goals. Commitment to collaboration and innovation
in C/T research remain top priorities as the CTSC implements its aims and builds the new iteration of the Clinical
and Translational Science Collaborative of Cleveland.

Public health relevance
The Clinical and Translational Science Collaborative (CTSC) of Cleveland has created a solid foundation to support its commitment to improve human health through the special expertise and population that Case Western Reserve University and its four partner hospital systems contribute to support clinical research and training in translational science. This foundation provides a collaborative environment and serves as a prototype to conduct and accelerate innovative clinical and translational research to benefit human health.